Diagnosing reactive oxygen species in bacteria

Bacteriologists have proposed that numerous stresses are toxic to bacteria because they
stimulate the intracellular production of superoxide and hydrogen peroxide. In most cases, no
molecular mechanism has been determined, and none is self-evident. Many of these proposals are
based upon data from redox-active fluorescent dyes, which are believed to detect intracellular reactive
oxygen species (ROS). However, those results have not always been supported by other more-direct
methods. This proposal includes preliminary evidence that highlights two concerns about these dyes:
that they can be oxidized by intracellular species other than ROS, and that the amount of dye that loads
into cells can be affected by stress. Aim 1 will systematically test the utility of fluorescein dyes, which
are oxidized by hydroxyl radicals, and ethidine dyes, which react with superoxide. Signals will be
quantified in E. coli strains in which ROS are adjusted over the range of biological relevance. Dye
signals will be normalized to their intracellular concentrations, using a novel technique. The result will
be a rigorous test of their validity as ROS sensors.
Aim 2 will develop an alternative marker of oxidative stress that is expected to be reliable,
relevant, and accessible to non-experts. Serine dehydratase is a widely distributed enzyme whose
iron-sulfur cluster is converted by oxidants to a unique [3Fe-4S] form that can be diagnosed through
simple in vitro methods. This Aim will optimize these measurements and test whether the enzyme
responds to the levels of ROS that are pertinent in vivo.
Aim 3 will then investigate two antibiotics whose toxic actions have been proposed to depend
upon intracellular ROS. Streptonigrin is thought to generate toxic amounts of H2O2 through redox-
cycling, with the H2O2 then reacting with drug-bound Fe(II) to produce fatal hydroxyl radicals. However,
an alternative model considered here suggests that redox-cycling may be minimal and free H2O2 may
not participate. Experiments will distinguish between these two hypotheses. Trimethoprim is an
inhibitor of thymine synthesis, and published data indicates that H2O2 can contribute to its lethality.
Authors conjectured that thymine-starved cells produce toxic amounts of H2O2. A different possibility is
that exogenous H2O2 creates DNA damage that thymineless cells struggle to repair. These two sub-
aims introduce several distinct ways in which ROS may drive the action of antibiotics. These concepts
and experimental approaches can guide the analysis of lead compounds whose antibiotic actions are
suspected of involving ROS.

Public health relevance
Reactive oxygen species (ROS) are proposed to underlie the toxicity of important antibiotics and antitumor agents, but these ideas have been challenged by contrary data and concerns about methodologies. The mechanisms of drug actions must be understood so that the drugs can be improved. This project will provide strategies to determine whether ROS play important roles in cell damage.